Mouse Cardiac Physiology and Surgical Core (Core C)

Abstract
The mouse is a powerful model organism for dissecting the underlying molecular and
genetic mechanisms leading to heart failure or cellular loss with ischemic injury. The
mouse will be the basis for all gene-disease relationship studies proposed in all 4 Projects
in the proposed Program. Core C will produce models of cardiac injury in a systematic
manner to ensure reproducibility and comparability across all 4 Projects so that results are
not influenced by model variability. Mice will be shipped as needed between Dallas and
Cincinnati for the proposed model production and analyses. The heart disease phenotype
will also be extensively analyzed in Core C, such as structure and functional assessment,
which will also be performed in a controlled and reproducible manner between the 4
projects, Core C will provide mouse models of ischemia-reperfusion injury (I/R),
myocardial infarction injury (MI), cardiac pressure overload induced by transverse aortic
constriction (TAC), and apical resection of the early neonatal mouse heart. For phenotypic
analysis of these mouse models, Core C will perform echocardiography, invasive
hemodynamics using a pressure sensing intraventricular catheter, and cardiac magnetic
resonance imaging (MRI). All 4 Projects will extensively use Core C, both the surgical
model generation capabilities and the functional assessment capabilities. Highly skilled
core personnel will ensure surgical consistency as well as data integration, uniformity, and
transparency across the 4 Projects. Core C approaches and services are essential for
cardiovascular structure and function analyses and will provide an indispensable
foundation and common linking point